DS-ARC: A Remote Digital Cognitive Assessment for Down Syndrome-Associated Alzheimer's Disease

PROJECT SUMMARY
The Down Syndrome – Ambulatory Research in Cognition (DS-ARC) study will develop and validate a
smartphone-based digital cognitive assessment designed specifically for participants at risk for Down
syndrome-associated Alzheimer’s disease (DS-AD). We will partner with sites in London, Barcelona, Munich,
and Gothenburg to develop and validate this approach in different cultures and languages. Nearly all
individuals with Down syndrome have elevated levels of Alzheimer’s disease (AD) biomarkers by the time they
are in their 30s or 40s, though not all show symptoms of AD. It is during the pre-symptomatic and early
symptomatic stages of DS-AD that an in-depth understanding of cognitive changes is crucial, as therapeutic
interventions to stop, slow, or prevent disease are focused on these critical periods. Typically, prevention trials
and observational studies in AD populations assess cognition with standard “table top” paper and pencil tests.
But these conventional methods have several drawbacks. First, performance is influenced by day to day
fluctuations in stress, fatigue, sleep patterns, and mood. Second, the testing takes place in environments that
are fundamentally different from where cognition is relied upon to function in daily life. Finally, by design,
cognition is typically assessed in “one-shot” in extended testing sessions on an annual or semiannual basis.
The DS-ARC study will address these difficulties by developing a smartphone-based assessment solution
adapted specifically for individuals with Down syndrome. This approach uses a measurement “burst” design in
which participants complete very brief cognitive tests on their smartphones several times per day for one week
while living in their natural environments. Instead of focusing on one of these measurements, tests are
averaged across the week to provide a score that captures and normalizes natural variability and dramatically
increases reliability. Studies of our original ARC assessments in autosomal dominant and sporadic AD
demonstrate extraordinary reliability and strong relationships with AD biomarkers, while reducing costly and
burdensome in-clinic evaluations. The study has two phases: a 2-year development phase and a 3-year
validation phase. In the development phase, we will adapt an existing smartphone application called the
Ambulatory Research in Cognition (ARC) app for use in DS-AD studies. This will include an iterative pilot
testing process for psychometrics and task development, focus groups and user experience testing to address
accessibility and compatibility concerns for DS-AD populations, and readiness audits to ensure that the DS-
ARC app meets strict compliance guidelines for clinical trial applications. In Phase 2, participants complete DS-
ARC assessments every 6 months and complete standard clinical, cognitive, and blood tests for AD
biomarkers annually. We hypothesize that DS-ARC assessments are accessible, sensitive, and reliable
indicators of cognitive change in DS-AD and will exhibit associations with AD biomarkers and disease stage
over and above those of conventional in-clinic assessments.

Public health relevance
PROJECT NARRATIVE People rely on cognitive abilities to function in situations and natural environments experienced in daily life, but research studies assess cognition in “one-shot” in a laboratory or clinical setting, which can yield unreliable results. This study will develop a smartphone app carefully designed to assess cognition with several brief (<3 min) tests per day over the course of a week in people with Down syndrome (DS) at risk for Alzheimer’s disease (AD). If successful, this study will provide new insights into DS-AD and could lead to faster results from clinical trials.